GASTRIC, SMALL INTESTINE AND COLONIC TRANSIT IN MOTOR DISORDERS OF GI TRACT

To further develop methods for diagnosing various GI motility disorders and to determine whether the present program of data acquisition and analyses can be simplified.